2009 Multi-drug Efflux Systems Gordon Research Conference

[unreadable] DESCRIPTION (provided by applicant): The phenomenon of resistance to chemotherapy continues to plague treatment of cancer and micro-organism infections. Whilst drug resistance should be considered a multi-factorial process the original "Multidrug Efflux Systems" GRC in 2003 highlighted the prominence and impact of drug efflux pumps in the phenotype. The long-term mission statement of the scientific community at this GRC was to provide a molecular description of the multidrug efflux process and to design inhibitors to overcome the actions of the pumps responsible for the phenomenon. The second GRC in 2005 focused on molecular aspects of resistance to chemotherapy including regulation and bio-energetics. In addition, there was considerable discussion of the clinical relevance and the wider biological impact of multidrug efflux pumps. Efforts to understand the mechanism of multidrug efflux has advanced steadily with significant input from active participants of the previous GRCs. However, a complete understanding requires the input of structural data and unfortunately this remains a difficult task for membrane proteins. Provision of structural data has begun in earnest and advances in expression systems and extraction techniques have brought us to the cusp for many efflux pumps. This aspect of research will be a particular focus for the "Multidrug Efflux Systems" GRC proposed for 2009. Structural information will comprise high resolution X-ray and electron microscopy data in addition to molecular modeling for proteins whose structures are not fully understood. A particular emphasis will be to relate structural information with biochemical data on drug-protein interaction and chemical synthesis of inhibitors. The emerging structural information thus heralds an exciting period in the quest to circumvent multidrug resistance in cancer and infections by parasites and bacteria. [unreadable] [unreadable] Public health Relevance: Treatment of bacterial and parasitic infections as well as cancer remains reliant on drug therapy. However, the treatments remain ineffective in the majority of settings due to the presence of resistance pathways; in particular, those related to the presence of drug efflux pumps. Understanding the mechanisms and structures of these pumps is urgently required to provide a means to circumvention of their unwanted actions. The GRC will focus on these specific key areas related to multi-drug efflux pumps in resistance. [unreadable] [unreadable] [unreadable]

Public health relevance
NARRATIVE: MULTIDRUG EFFLUX SYSTEMS Treatment of bacterial and parasitic infections as well as cancer remains reliant on drug therapy. However, the treatments remain ineffective in the majority of settings due to the presence of resistance pathways; in particular, those related to the presence of drug efflux pumps. Understanding the mechanisms and structures of these pumps is urgently required to provide a means to circumvention of their unwanted actions. The GRC on will focus on these specific key areas related to multi-drug efflux pumps in resistance.